Ultra-sensitive, unbiased, high-throughput, biochemical CHANGE-seq genome-wide activity and gRNA sequencing assays for therapeutic genome editing INDs

PROJECT SUMMARY
Genome editors, technologies to modify the genomes of living cells, have extraordinary potential to become
safe and effective genomic medicines, direct treatments for the underlying cause of genetic diseases such as
sickle cell disease and many others. However, as gene therapy products with novel mechanisms of action, there
remains a need for optimized and qualified biochemical IND-enabling assays to assess their safety. We and
others have developed sensitive and unbiased research methods for defining the genome-wide activity of editors
such as CHANGE-seq and GUIDE-seq. However, they require further optimization and characterization as fit-
for-purpose assays to fulfill rigorous regulatory requirements for investigational new drug (IND) submissions.
Surprisingly, to our knowledge there are no published methods for high-throughput sequencing characterization
of gRNA identity and purity. Thus, there remain urgent unmet needs for publicly available, optimized, and
qualified IND-enabling assays to characterize critical genome editing reagents and their associated on- and off-
target genome-wide activities. We, therefore, propose the following specific aims: 1) Optimize and qualify
CHANGE-seq as IND-enabling biochemical genome-wide activity assay, and 2) Optimize and qualify gRNA
sequencing as IND-enabling assay to assess genome editing component identity and purity, and 3) Collaborate
to test CHANGE-seq and gRNA sequencing in therapeutic contexts. We anticipate that fulfilling the need for
well-characterized assays to identify impurities in critical reagents or characterize key quality attributes of
genome editing drug products will have positive impact to accelerate the translation of novel, safe, and effective
therapeutic genome editing therapeutic strategies to first-in-human clinical trials.

Public health relevance
PROJECT NARRATIVE Genome editing technologies like nucleases, base editors, and prime editors may become safe and effective genomic medicines to treat monogenic human diseases either ex vivo or in vivo. Although fit-for-purpose biochemical methods like CHANGE-seq and gRNA sequencing have advantages as highly-sensitive IND- enabling assays for nucleases and base editors, to our knowledge, fully optimized and qualified protocols for use in regulatory submissions are not generally available. Here we propose to optimize and qualify CHANGE- seq adapted for nucleases and base editors, and associated gRNA sequencing, for use in future therapeutic genome editing INDs.